17α-estradiol and sex-differences in HAND with methamphetamine

Project Abstract
The pathogenesis of HIV-associated neurocognitive disorders (HAND) in ART era is complex and may result
from low levels of HIV-1 replication/HIV-1 proteins, ART drugs, drug of abuse, and the misuse of stimulants
such as methamphetamine. It is envisioned that combined exposure of these HIV-related factors leads to
reversible synaptodendritic impairment that contribute to the development of HAND. Growing evidence
indicates the existence of sex differences in both HAND and in methamphetamine misuse; Women living with
HIV have greater neurocognitive impairments, and methamphetamine misuse leads to more severe gray
matter damage and cognitive deficits in female. One factor for these sex-differences is estradiol (E2), a major
form of estrogen with two isoforms (17β-E2 and 17α-E2). Although both isoforms are neuroprotective,17α-E2,
the predominant estrogen in the brain, may play an important role in HAND. Significantly, our findings indicate
that endolysosomes represent as critical sites, where 17α-E2, HIV proteins (gp120 and Tat), ART drugs, and
methamphetamine could intersect to affect synaptodendritic impairment and sex-differences in HAND.
Endolysosomes are important for important in modulating neuronal plasticity because their extensive
processes require constant vesicular membrane trafficking to maintain axonal and somatodendritic
membranes. Endolysosome dysfunction resulting from combined exposure of HIV-related factors could lead to
synaptodendritic impairment. Conversely, the endolysosome enhancing effect of 17α-E2 could reverse
synaptodendritic impairment and contribute to sex-differences in HAND. The objective here is to investigate the
role of endolysosomes in synaptodendritic impairment and sex-differences in HAND. We will test the
hypothesis that endolysosome localization of estrogen receptor-α (ERα) is critical for the protective effects of
17α-E2 against endolysosome dysfunction and synaptodendritic impairments resulting from combined
exposure of HIV-related factors (gp120, Tat, ART drugs, and methamphetamine). Guided by our preliminary
findings, our novel hypothesis will be tested by pursuing two specific aims. (1) Determine the role of ERα in the
protective effects of 17α-E2 against endolysosome dysfunction and synaptodendritic impairments, resulting
from combined exposure of HIV-1 proteins (gp120 and Tat), ART drugs, and methamphetamine. (2) Determine
the extent to which 17α-E2 affects cognitive impairment and the development of endolysosome dysfunction
and synaptodendritic impairments in HIV-1 Tg rats exposed with ART drugs and/or methamphetamine. The
proposed work is focused to determine the novel role of 17α-E2 and endolysosomes in sex-differences in
HAND with misuse of methamphetamine. Mechanistically, endolysosomes are critical sites, where 17α-E2, HIV
proteins, ART drugs, and methamphetamine intersect to affect synaptodendritic impairment and sex-
differences in HAND. The therapeutic potential of 17α-E2 will be determined using in vitro and in vivo models.
Results of these studies will help in understanding better sex-differences in HAND in the context of misuse of
methamphetamine and may provide a solid mechanistic basis for the development of 17α-E2-based therapies
against HAND. Thus, our proposed studies are responsive to NOT-DA-21-020 (Evaluation of sex differences
on HIV-associated comorbidities in the context of stimulant use).

Public health relevance
Project Narrative The prevalence of HIV-associated neurocognitive disorders (HAND) remains high even with antiretroviral therapy, and there exists sex-differences in HAND; However, the underlying mechanisms remain elusive. The proposed studies are focused to determine the protective effect of 17α-estradiol, the predominant form of estrogen in brain, against brain damage resulting from combined exposure of HIV-1 viral proteins (gp120 and Tat), antiretroviral drugs, and methamphetamine. Findings are expected to provide novel insights into sex-differences in HAND and provide new targets and rationale for preventative and therapeutic interventions against HAND.